TREATMENT OF INSECT STING ALLERGY IN CHILDREN

Venom immunotherapy, already shown to be highly effective in prevention of insect sting anaphylaxis in previously sensitized patients, remains effective but brings little benefit to patients age 2-16 years whose systemic reactions were limited to the skin. Lack of benefit in this group stems from a repeat reaction rate in unimmunized patients much lower than expected from previous experience with insectallergic adults. This disparity will allow us to probe whether the low reaction rate is a function of age, reaction type (cutaneous vs. respiratory, mucosal or cardio-vascular) or another variable. Additional goals include exploration of whether in vivo or in vitro parameters of decline in anti-venom IgE antibodies can be correlated with clinical evidence of attenuation of the venom-allergic state. We shall continue to document the natural history of insect sting allergy without immunotherapeutic intervention in mildly affected children.